LONG TERM FOLLOW-UP OF PATIENTS TRANSPLANTED WITHOUT TOTAL BODY IRRADIATION

Bone marrow transplant recipients who receive total body irradiation have difficulty with neuropsycological function, growth,endocrine function and secondary malignancies. To determine if transplantation without total body irradiation but with busulfan, has less side effects, we will longitudinally evaluate patients who receive busulfan to those who receive total body irradiation for therapy related side effects.